Rehabilitation Exercises for Cognitive, Oculomotor, and Vestibular Recovery (RECOVER)

Project Summary/Abstract
Over the last 20 years, traumatic brain injury (TBI) has been increasingly recognized as a significant health
problem that can result in acute, subacute, and chronic neurological deficits. Individuals with concussions can
display a wide array of symptoms, including physical (e.g., headache, nausea, vomiting), behavioral and
emotional (e.g., drowsiness, irritability, sleep problems), and cognitive (e.g., attention or memory) deficits.
Commonly, vestibular and oculomotor deficits occur. Interventions can reduce the amount of time needed to
return to activity after TBI but a major obstacle to the real-world implementation of TBI rehabilitation is the lack
of affordable, accessible, and effective platforms that are adaptable to the wide individual variability of symptoms
associated with TBI. A virtual reality (VR)–based rehabilitation system with multidomain and adaptive rehab
protocols could accelerate recovery and reduce functional impairments after TBI by providing highly controlled,
immersive, and ecologically valid stimuli that promote sensorimotor adaptation and neural plasticity. Such a
system must deploy robust rehabilitation tasks coupled with an easy-to-use user interface (UI) that allows for
both in-person and remote administration of therapeutic tasks.
To solve this problem, Charles River Analytics will develop a TBI rehabilitation system called RECOVER
(Rehabilitation Exercises for Cognitive, Oculomotor, and Vestibular Recovery). RECOVER is a robust, adaptive,
and effective tool for providing sensory, motor, and cognitive rehabilitation after TBI. Charles River has previously
developed a diagnostic tool for TBI called Assessment and Diagnosis of Vestibular Indicators of Soldiers'
Operational Readiness (ADVISOR) that uses a VR headset with integrated eyetracking to assess vestibular and
oculomotor function (VOF) associated with TBI. While ADVISOR is designed as a diagnostic tool, under this
award we will develop RECOVER to extend the ADVISOR platform to focus on rehabilitation. We will develop
an intuitive and highly usable web application UI to enable clinicians to configure and administer rehab tasks and
track patient progress in both in-person and telehealth settings. RECOVER can both stand alone as a therapeutic
tool and be used as a supplement to ADVISOR to create a single integrated system capable of both diagnosis
and assisting with rehabilitation of TBI.

Public health relevance
Project Narrative Mild traumatic brain injury (TBI), commonly referred to as concussion, is a major public health problem that can result in significant acute, subacute, and chronic neurological deficits. RECOVER is a robust, adaptive, and effective tool for providing sensory, motor, and cognitive rehabilitation after TBI. RECOVER builds upon an established diagnostic system for TBI to provide accessible, affordable, and effective interventions to promote faster and more complete recovery after concussion.